Chronic Postsurgical Pain Across the Lifespan: Brain State and Treatment

Project Summary
Statement of the Problem:
Chronic post-surgical pain (CPSP), defined as pain lasting longer than two-months after surgery, is a significant
public health problem affecting up to 80% of patients presenting for surgery. There are far-reaching
consequences for quality of life and physical and emotional functioning for those affected by CPSP and
complicating this crisis is the number of opioids prescribed after surgery with over 80% of patients receiving
opioid prescriptions after low-risk surgery. Integrative research and effective treatment strategies are lacking.
Overview of Research in the Laboratory:
My grant funded research, including my current K23 Award, has focused on identifying biopsychosocial
predictors of CPSP through the use of pre-clinical and clinical models and assuming a life-span perspective for
identifying predictors and prevention of CPSP. In 2013, I published the largest prospective study to date
identifying long-term pain trajectories and predictors of CPSP in young people and in 2018 results of Aim 1 of
my K23 Award, utilizing an animal model of CPSP, received Editor’s Choice. My approach is to integrate clinical,
psychological, and brain measures in order to understand the neurobiological processes that contribute to the
evolution or resilience of CPSP.
Goals for the Next 5 Years:
In the next 5 years, I will continue to utilize a translational approach to examine risk factors for CPSP and extend
upon my K23 work to: 1) utilize psychophysics and neuroimaging to understand the effects of CPSP on synaptic
plasticity from adolescence into adulthood and 2)
evaluate the effects of an evidence-based behavioral pain
intervention, compared to Treatment as Usual, on the fNIRS signal in groups of adolescent and adult patients
diagnosed with CPSP in order to compare Responders (improvement in pain severity, interference, &
functioning) vs. Non-Responders.
The projects outlined in the MIRA will be accomplished by my continued
collaborations with colleagues who have expertise in surgery, pain psychophysics, neuroscience, and
neuroimaging.
Overall Vision of the Research Program:
The goals of the R35 will be to: 1) enhance our understanding of the neurobiology of CPSP; 2) provide a metric
to follow patients with CPSP in the clinic; 3) provide a metric for those who will chronify; 4) understand the age-
related differences in CPSP; and 5) define an initial paradigm that may enhance our capability for developing
individually tailored patient-oriented interventions at both a behavioral and pharmacological level.

Public health relevance
Project Narrative Chronic post-surgical pain (CPSP) is a significant public health concern affecting up to 80% of adults who have undergone surgery and is a contributor to the opioid epidemic. Identification of biopsychosocial risk factors is crucial for pain prevention and more effective treatment strategies. The proposed translational research plan will utilize a prospective study design as well as a mechanistic clinical trial to address substantial gaps in the literature, including neurological mechanisms underlying behavioral treatment response.